TABA: Proactive Dual-Irrigation Cardiac Chest Tube to Maintain Postoperative Patency

Abstract
Over 455k cardiac procedures annually rely on chest tubes to drain blood from surgical wounds. However,
dated chest drainage technologies result in significant issues—36% of tubes clog with blood, leading to
complications in 17% of patients due to incomplete drainage. Hospitals spend approximately $9,617 per
patient on these complications, totaling a yearly economic burden surpassing $2B in the US alone. The current
practice of milking and stripping chest tubes is both labor-intensive and potentially risky, often leading to
missed clots that compromise tube patency and patient adverse outcomes.
CirculaTech’s ThoraFlush is a proactive clot preventing chest tube which utilizes proprietary dual irrigation
technology to sustain drainage patency. ThoraFlush integrates seamlessly with hospital IV pumps to irrigate
the chest tube with saline, obviating the labor-intensive manual manipulation, and automating chest tube
maintenance. ThoraFlush saves nurses time and effort in maintaining chest tubes, reduces hospital costs
linked to tube blockages, and promotes faster, smoother patient recovery with fewer complications.
This NIH proposal will complete the following AIMs: 1) Optimize ThoraFlush’s efficacy of drainage patency in a
mediastinum blood coagulation model (MBCM). 2) Sustaining ThoraFlush’s drainage volume in an in vivo
model, superior than the standard of care.
In AIM 1, the team will use an in vitro bench top mediastinum blood coagulation model, known as the MBCM to
produce a functioning ThoraFlush prototype. The MBCM is hypothesized to be more rigorous than clinical
practice due to its use of hypercoagulable porcine blood and mediastinal model geometries/materials
promoting accelerated blood clot formation. Achieving a 6 hour benchmark of retaining device patency will
prove significance to move to conducting AIM 2.
In AIM 2, the team will translate their work in Aim 1 to animal testing using male Yorkshire Breed pigs to assess
ThoraFlush's efficacy in live animals. The study involves a simulated heart surgery, replicating common cardiac
procedures. This approach aims to comprehensively evaluate ThoraFlush's performance in a relevant
physiological context. This model also proves as a first of its kind, mediastinum in vivo model for post-surgical
recovery.
Ultimately, the outcomes of this proposal will develop and prove that ThoraFlush meets patency requirements
in the MBCM and show’s superior performance in an in vivo study, promoting its next stages into
commercialization of the device.

Public health relevance
Narrative Surgical drains, common to cardiac surgeries, often fail to adequately retain chest tube patency in post-surgical care leading to complications from incomplete drainage of retained blood. CirculaTech will advance methods and technologies in preventing surgical drain blockages, namely to enhance the understanding of saline irrigation in averting clogs in surgical drains and to develop an in vivo porcine model mimicking post-cardiac surgery blood drainage. Development of this technology will prevent post-surgical cardiac complications caused by retained blood resulting from occluded chest drains.